Spatiotemporal Health Analytics: Geospatial connections to toxicology

Within environmental health sciences, there is an ever-growing need for methodological development and applications of spatiotemporal models that can handle the large, complex data and interdisciplinary challenges. Towards this end, the Spatiotemporal Exposure and Toxicology Group (1) elucidated novel health effects from complex air pollution mixtures on under-studied skin autoimmune diseases, (2) developed an exposure source to outcome framework and open-source software for exposomic risk assessment, and (3) develop novel geostatistical methods for large scale, efficient mapping of the space/time distribution of environmental chemical exposures.